Targeting Signaling Pathways with Small Molecules in Osteoarthritis

Abstract: “Targeting Signaling Pathways with Small Molecules in Osteoarthritis”
One of today’s greatest needs in managing osteoarthritis (OA) is an intervention that stops or delays joint
tissue destruction and progression to “joint failure”. The overall goal of this exploratory/developmental project is
to use a novel high throughput small molecule screening (HTS) technology combined with CRISPR screening
and target prioritization tools to identify signaling pathways and therapeutic targets for disease modification in
OA. The pathobiological processes that promote OA result from activation of cell signaling pathways and
subsequent changes in gene transcription mediated by a host of factors. The complexity of OA explains why a
single target approach for disease modification has met with limited success. We propose that use of small
molecules to target pathways that regulate expression of multiple OA mediators will represent a viable and
more promising approach. We have established a robust cell-based high throughput functional screening
(HTS) assay using normal human chondrocytes treated with a matrikine relevant to OA progression. We found
this system to be a valid in vitro model of the OA chondrocyte phenotype that allows us to investigate multiple
pathways and targets, providing a distinct advantage over single target analysis.
Our aims are: Aim 1: Identify OA signaling pathways and potential therapeutic targets through high throughput
cell-based compound screening, network analysis of genetic and genomic datasets, and CRISPR screening.
Aim 2: Determine the ability of compounds that target prioritized pathways to restore the catabolic and
anabolic balance in joint tissues. At the completion of the project, we expect to: 1) identify one or more new cell
signaling pathways contributing to dysregulated catabolic and anabolic activity in OA joint tissues; 2) identify
specific therapeutic targets within those pathways; and 3) discover small molecules for further testing in
preclinical models of OA. These outcomes would serve as the basis for lead optimization and further
development of disease-modifying drugs for OA in humans.

Public health relevance
Project Narrative Current osteoarthritis (OA) management only targets symptoms and for many patients is ineffective, resulting in unchecked disease progression and ultimately the need for joint replacement. The goal of this research project is to address the unmet need for therapeutics that target mechanisms responsible for joint tissue destruction in OA and thereby halt or slow disease progression, resulting in significant benefits to patients suffering from this chronic disabling condition.